HDPTP

Program Summary/Abstract This is a supplemental proposal for a coronavirus and infectious disease response training program to be implemented by The New England Consortium-Civil Service Employees Association (TNEC-CSEA), a partnership between the University of Massachusetts Lowell (UML), four New England coalitions for occupational safety and health (COSH groups) in Massachusetts, Rhode Island, Connecticut, and New Hampshire, and CSEA, Local 1000 AFSCME, in New York. Since 1987, TNEC has been providing participatory hands-on HAZWOPER training to workers throughout the New England region. In addition to HAZWOPER training, the COSH organizations provide a diversified set of health and safety training programs for labor unions, community organizations, school personnel, and other groups and individuals. CSEA represents 300,000 public sector workers in New York State and has been part of AFSCME’s NIEHS WTP-awarded training program since 2003 and provided substantial direct training from 2007 until joining TNEC. CSEA has built effective internal health and safety management systems through site-specific hands-on training and uses a labor-management cooperative peer-trainer model with 150 active Peer Trainers, 24 of which have been involved for ten or more years, and part of the Emergency Management Operations Protocol to be deployed in emergencies and disasters. TNEC/New England’s previous experience in infectious disease training includes: in 2008-09, delivery of seven 6 to 7 hour Train-the-Trainer courses on avian flu pandemic preparedness to Massachusetts public school teachers, who then delivered training back in their school districts; and in 2014, delivery of Ebola-related training to 190 workers including employees of the New Hampshire Department of Public Health, members of the Massachusetts State Police, and for leaders of the Massachusetts Nurses Association. Altogether, TNEC will deliver 29 courses for 1,010 students for 2,920 contact hours in New England. CSEA will complete approximately 145 sessions for 1,142 participants for 1,376 contact hours in New York of mostly interactive online coronavirus/COVID-19 and infectious disease response training. These trainings will include: overview of the SARS-CoV-2 virus; workers’ rights; assessing exposure; prevention in the workplace; personal protective equipment; keeping yourself safe; cleaning & disinfecting and returning to work; hazard communication/Safety Data Sheets; PPE for cleaning & disinfecting; cleaning & disinfecting delivery systems; and mental health well-being. Our target populations are: 4,831,010 essential personnel in the six New England states and 300,000 frontline workers in the public sector within New York state. TNEC- CSEA seeks to build sustainable capacity for CSEA peer trainers and TNEC/New England trainers to deliver ongoing COVID-19 and infectious disease response trainings that will reduce exposures and increase the capacity of employers and workers to identify and mitigate the occupational risk factors caused by COVID-19 and infectious diseases with a focus on reaching vulnerable populations.

Public health relevance
Project Narrative This is a supplemental proposal for a coronavirus and infectious disease response training program to be implemented by The New England Consortium-Civil Service Employees Association (TNEC-CSEA), a partnership between the University of Massachusetts Lowell (UML), four New England coalitions for occupational safety and health (COSH groups) in Massachusetts, Rhode Island, Connecticut, and New Hampshire, and CSEA, Local 1000 AFSCME, in New York. Altogether, TNEC will deliver 29 courses for 1,010 students for 2,920 contact hours in New England. CSEA will complete approximately 145 sessions for 1,142 participants for 1,376 contact hours in New York of mostly interactive online coronavirus/COVID-19 and infectious disease response training.